Employing the gut microbiome to accelerate effective initiation of rheumatoid arthritis therapy

Title: Employing the gut microbiome to accelerate effective initiation of rheumatoid arthritis therapy
ABSTRACT
Rheumatoid arthritis (RA) is a complex, multifactorial, autoimmune disorder that affects ~1% of the worldwide
population (~2 million adults in the US alone). It is characterized by chronic synovitis that, when left untreated,
can result in irreversible joint destruction and deformity, leading to increased morbidity and all-cause mortality.
The last three decades have witnessed impressive advances in the understanding of disease pathogenesis and
therapeutic outcomes. In fact, the use of methotrexate first, and the subsequent incorporation of anti-TNF (TNFi)
and other “biologics” have led to substantial improvements in RA clinical outcomes, enhancing the quality of life
for millions of patients with inflammatory arthritis. Despite this progress, however, a significant question still
remains unanswered: why do over 50% of RA patients with moderate to severe arthritis fail to respond
appropriately to these agents? Pharmacomicrobiomics – an emerging field of study that investigates the effect
of variations within the human gut microbiome on drugs – promises to overcome these barriers and facilitate
precision medicine approaches in autoimmune disease.
Methotrexate (MTX), a dihydrofolate (DHF) reductase inhibitor, remains the anchor drug for the treatment of
RA and is used widely throughout the world. While quite effective, oral MTX achieves significant results in less
than 50% of patients and remission in only a quarter of them. It is well established that the inter-individual
bioavailability of MTX is extremely variable, ranging from 10 to 80%. The reasons for this are presumably
multifactorial. However, the intestinal microbiome and its enzymatic machinery are likely to play a significant role,
based on our Preliminary Results and given that animals treated with antibiotics or kept under germ-free
conditions show significant differences in MTX metabolism relative to control animals.
Our multidisciplinary team composed of rheumatologists, bioinformaticians, pharmacologists and
microbiome researchers will address our overarching goal to study: a) if baseline intestinal microbiome, its
genes, and associated metabolites can be used to predict the immunomodulatory responses to MTX in
treatment-naïve, new-onset RA (NORA) patients; and b) if the gut microbiomes of MTX non-responders can be
manipulated to modulate MTX metabolism and bioavailability. We believe that the results of our highly
translational, innovative studies will directly influence therapeutic approaches for the treatment of RA and offer
a more personalized approach in which the clinical efficacy response would be predicted early (and potentially
improved by microbiome-targeted adjuvant therapies) in any given patient about to initiate MTX, limiting or
preventing disease progression and ultimately avoiding wasteful health expenditures (estimated as
~$50,000/year/patient in direct costs). Importantly, we anticipate that our studies will establish generalizable
approaches in rheumatology and autoimmunity that could be more broadly applied to the study and clinical
maximization of other similar small molecules (e.g., JAK inhibitors) or even biologic agents (e.g., anti-TNF mAbs).

Public health relevance
NARRATIVE Rheumatoid arthritis (RA) is a chronic, autoimmune disease characterized by widespread musculoskeletal inflammation affecting 1% of the world’s population (including ~2 million adults in the US alone). While the use of methotrexate (MTX) has significantly improved the lives of many people with RA, over 50% of patients do not respond adequately to this drug. Successful completion of our proposed studies will provide key insights into the effects of the gut bacteria on MTX and the implications for prediction of clinical response, ultimately identifying patients that are either likely to improve even before this treatment is prescribed, or those that would benefit from microbiome-targeted interventions to improve MTX absorption and efficacy.